Cloud-Based Machine Learning and Biomarker Visual Analytics for Salivary Proteomics

Title: Cloud-Based Machine Learning and Biomarker Visual Analytics for Salivary Proteomics
PROJECT SUMMARY
Cloud computing and open-access data platforms provide essential and critical bioinformatics resources
for data analysis and knowledge discovery to support data-intensive and data-driven research such as
proteomics. The parent grant for this supplement proposal, DE016937, “A Foundation for the Oral
Microbiome and Metagenome,” has the goal of providing curated ‘omic resources to help the scientific
community understand how microbe-microbe and microbe-host interactions in the oral cavity affect
human health and disease. Saliva is a biofluid with complex composition and function that has the
potential to allow the medical community broadly to diagnose and treat disease. This is a proposal to
test the utility of cloud-based resources to improve understanding of saliva and its associated large
proteomic datasets. This information will integrate into the parent grant via the Human Salivary Proteome
Wiki - HSP Wiki – which was developed to aggregate and curate proteome information from human
saliva. Currently, this database allows members of the oral and biomedical research communities to
explore various proteomic datasets, with limited visualization tools for salivary composition, interactions,
and initial clustering. While our HSP Wiki pipeline allows users to interrogate the data by surveying health
and disease patterns, there are gaps in salivary biomarker discovery, including lack of visual analytic
tools and tools to study protein-protein interactions. In addition, most cutting-edge machine learning (ML)
methods have not been applied to proteomic data analysis, including of the salivary proteome. The goal
of this proof-of-concept project is to develop cloud-based tools to enhance the current HSP Wiki visual
analytics, implement ML and improve our interpretation of salivary derived proteins towards more efficient
and reliable salivary biomarker discovery. With this purpose, the first aim is to develop a cloud-based
visual analytics platform to support machine learning identification of salivary proteomic biomarkers. We
will test and quantify how parallel computing and machine learning can effectively and efficiently process
large salivary proteomic datasets for novel biomarker discovery when compared to conventional desktop
tools. The second aim is to develop a scalable and on-demand cloud pipeline to implement protein
prediction using AlphaFold2, and a comparison tool for 3D models using MolStar. The expected outcome
will be to provide the research community with enhanced tools and online resources to better discover
biomarkers in health and disease and for both host and microbial proteins. We will quantify the efficiency
of these tools and their effectiveness in generating new discoveries of protein structure. The cloud-based
interface, visual analytical tools, informatic pipelines, and parallel computing will be broadly disseminated
to catalyze discovery, enhancing rigor and transparency in proteomic research and translation
applications to salivary biomarkers.

Public health relevance
PROJECT NARRATIVE We aim to assess the impact of cloud-based resources on salivary proteomics by developing novel cloud- based tools and pipelines to investigate the composition and function of the proteins in saliva. The informatic pipelines will lead to better visualization and analytical potential to dissect human samples from health and disease and create better understanding of protein-protein interactions. By improving the precision of our salivary analytics, this project will lead to increased chances to discover new biomarkers in saliva and will provide a better understanding of protein-protein interactions, which is potentially important for developing new treatments for disease.